LAMb Request for Edstrom PULSE Environmental Monitoring System for Veterinary Medical Unit

The Edstrom Pulse CMCTM System uses the latest sensor technology, along with a web-based platform to provide the Veterinary Medical Unit staff, at the Jesse Brown VA Medical Center, environmental data points for the vivarium in real-time. Our unit will be equipped with lighting and temperature monitoring with parameters in place to alert our staff of any deviations from our environmental guidelines. Approximately 30 protocols between 16 investigators are housed within our unit. All colonies for these protocols will be monitored by this system, allowing constant communication with our staff and the ability to react quickly to any disasters or outages that affect our unit.

Public health relevance
The Edstrom Pulse CMCTM System will provide an enhanced level of environmental monitoring for the animals housed within the Veterinary Medical Unit. Proper care and environmental consistency will give the opportunity for the researchers to obtain viable data for their projects. These findings will then be used to begin clinical trials to find cures, develop new drugs and maintain adequate health for the patients within our Veterans health care system.